Specification of Functional Characteristics of Spinal Cord Interneurons

Summary/Abstract This is not required for PA?18-906 Diversity Supplement

Public health relevance
Project Narrative This is not required for PA‐18-906 Diversity Supplement